FMRP regulation of mitochondria and metabolism in mammalian brain development

Neuronal activity is critical for brain development and altered activity-dependent plasticity is found
in neurodevelopment disorders. RNA binding protein FMRP, encoded by the X-linked Fragile X
Messenger Ribonucleoprotein 1 (FMR1) gene, has been shown to regulate activity-dependent
neuronal function and plasticity. FMRP loss of function leads to fragile X Syndrome (FXS) 7-9, the
most common heritable cause of intellectual disability and a top contributor to autism spectrum
disorders (ASD). Despite extensive interest, the mechanisms underlying FXS and FMRP
regulation, especially in humans, are not fully clear. Neurons have high energy demand and both
mitochondrial content and oxidative phosphorylation increase during neuronal maturation and
activation. We published the first paper to show that FMRP deficiency in mouse neurons leads to
mitochondrial fragmentation and impaired mitochondrial function. To translate these exciting
findings into humans, we assessed human pluripotent stem cells (hPSCs)-differentiated neurons
and discovered that FMRP-deficient human neurons have not only mitochondrial fragmentation
but also reduced amount of mitochondria. In addition to MFNs, human FXS neurons also have
reduced PGC1α (PPARGC1A), a master regulator of mitochondrial biogenesis and energy
metabolism. We and others have shown that human FXS neurons exhibit hyperexcitability in the
absence of stimulation. Our preliminary study found that human FXS neurons had reduced
response to neuronal activation stimulus. Using CLIP-seq we have identified RACK1 (Receptor
for Activated C Kinase 1) as a direct target of FMRP in human but not mouse neurons. RACK1-
defieicent human neurons phenocopy mitochondrial deficits and hyperexcitability of human FXS
neurons and exogenous RACK1 rescues deficits of human FXS neurons. RACK1 is essential for
both human and mouse development; however, the role of RACK1 human neuron development
is unknown. We hypothesize that FMRP is required for neuronal activity-dependent mitochondrial
biogenesis and energy metabolism during human neuron development and RACK1 is a key
mediator of such regulation. We will investigate the impact of FMRP and RACK1 deficiency on
activity-dependent mitochondrial dynamics and functions in human neurons; determine the
mechanisms underlying RACK1 regulation of mitochondrial dynamics and energy metabolism in
human neurons, and comprehensively characterize proteome and metabolome of FXS human
neurons. The proposed work will fill a major gap of our knowledge in understanding metabolic
regulation in human neuron development, which is critical for therapeutic development for FXS,
ASD, and other brain disorders.

Public health relevance
PROJECT NARRATIVE The proposed work will fill a major gap of our knowledge in understanding function of FMRP in regulating energy metabolism during human brain development. Such understanding is critical for better therapeutic development for fragile X syndrome as well as other neurodevelopmental disorders including autism.